Delivery optimization of a transarterial ablative therapy

Project Summary
This project will address several important open issues related to transient multiphase ﬂow and heat transfer
in biological tissues, including formulation of a class of mathematical models that satisfy conservation laws of
multi-constituent chemically reacting ﬂow through porous tissue and stable time-stepping schemes for efﬁcient
solution to the highly nonlinear and degenerate coupled governing equations. Mathematical models of chemically
reacting miscible ﬂuid ﬂow in living porous tissue will include all relevant phenomena: mass-momentum-energy
conservation of multiple chemical species, exothermic chemical reactions during delivery and within the tissue,
as well as liquid-gas phase changes induced by exothermic acid-base neutralization reactions. To focus math-
ematical model developments, research will develop a class of mathematical models toward understanding the
fundamental thermal, hypoxic, and pH response of an exciting thermoembolization therapeutic approach for treat-
ing hepatocellular carcinoma (HCC). Mathematical predictions will be validated in an animal model of HCC. The
validated models will be used to optimize delivery protocols. The goal of these mathematical sciences efforts is to
provide fundamental understanding of mechanisms that deﬁne a successful treatment. Our high-ﬁdelity mathe-
matical approach will provide guidance toward the treatment extent that can be achieved for a given combination
of patient anatomy, disease extent, chemistry, and injection parameters. Further, the computational methodology
is cost effective and helps to reduce and reﬁne animal experiments. A multi-disciplinary team with expertise in
imaging physics, mathematical modeling, numerical algorithms, interventional radiology, and biochemistry has
been assembled to accomplish project goals.

Public health relevance
Project Narrative Research will investigate mathematical models of chemically reacting multicomponent multiphase ﬂuid ﬂow in living porous tissue. Mathematical models will provide fundamental understanding of the ischemic, thermal, and chemical stress response to a novel thermoembolization approach for treating patients with hepatocellular carcinoma (HCC). Our validated numerical simulation approach will guide optimal thermoembolization delivery.